Impact of Antimicrobial Stewardship Resources on Reducing Dog Owners' Expectation of Antimicrobial Drugs

PROJECT SUMMARY
Since any antimicrobial drug use has the potential to increase resistance, a key goal is to align antimicrobial drug
use (AU) with the prescribing guidelines in veterinary settings. Pet owners have expressed a preference for
receiving antibiotics over watchful waiting including in cases where the benefit of antibiotics is unclear and a lack
of awareness of the risk of antimicrobial use on their pets and the greater society have been found to be barriers
to judicious use. Information is lacking on the impact of available educational resources to reduce dog owners'
intentions to request antibiotics and increase their confidence in alternatives to antimicrobial drugs. Since 45.5%
(59.8 million) households own an estimated total of 89.7 million dogs, and since up to 70% of dogs receive
antibiotics for the treatment of acute diarrhea, it is crucial to test the impact of targeted resources designed to
persuade dog owners that antimicrobials are not needed in these cases.
To foster antimicrobial stewardship in veterinary settings using training or education tools, we will use the Theory
of Planned Behavior to quantify the knowledge, attitude, subjective norm (perceived social pressure regarding
guidelines), and perceived behavioral control (perceived ability to follow the guideline) related to requesting
antimicrobials for dogs with a common medical condition (i.e., acute diarrhea). We will explore whether a short
educational video on antimicrobial stewardship or a handout summarizing evidence-based guidance with
accompanying citations can impact dog owners' opinions on antibiotics for canine acute diarrhea and define
characteristics of antimicrobial use resources that dog owners identify as effective in changing their intention to
request antimicrobials for canine acute diarrhea.
The impact of these resources will be assessed using a cross-sectional survey of dog owners in the United
States randomized to 3 arms (no resource, educational video, written summary of evidence-based guidance)
followed by focus groups with participants drawn from each group to define which aspects of AS resources are
effective in reducing dog owners' intent to request antimicrobial drugs and confidence in alternatives to
antimicrobial drugs. The outcome of these aims will facilitate a greater understanding of the potential impact of
AS resources on aligning dog owners' expectations for antibiotics with prescribing guidelines and inform further
research into the creation and implementation of resources for dog owners to further the goals of antimicrobial
stewardship.

Public health relevance
PROJECT NARRATIVE This research will quantify the extent to which certain characteristics of educational tools can increase dog owners' intention to follow antimicrobial stewardship guidelines related to canine acute diarrhea. We will explore whether a short educational video on antimicrobial stewardship or a written handout with the same messaging can impact dog owners' intention to request antibiotics and confidence in alternatives to antibiotics during episodes of canine acute diarrhea and define characteristics of antimicrobial use resources that dog owners identify as effective in changing their expectation of antimicrobial prescribing for canine acute diarrhea. We will use the Theory of Planned Behavior to quantify the knowledge, attitude, subjective norms (perceived social pressure regarding guidelines), and perceived behavioral control (perceived ability to follow the guideline) related to requesting antibiotics for dogs with a common medical condition (i.e., acute diarrhea).